Developing Clinical Decision Support Systems Adaptive to Clinicians' Fatigue (Cessation Fatigue)

Abstract: Fatigue is a latent hazard in health care, (particularly in emergency departments-ED), leading to
poor judgement and increased medical errors. Fatigue-induced adverse events have negative financial and
patient/occupational safety impact in EDs and other settings. Commonly used time- and task-management
strategies (e.g., multitasking), are much less effective in clinicians with fatigue. Potential causes,
consequences, and fatigue-induced adverse events, have been studied, however interventions to mitigate risks
is limited. Currently proposed solutions to obviate fatigue (e.g., limit working hours, decreased patient load) can
be helpful, but fatigue is a complex construct, making it less feasible to develop uncomplicated solutions.
Decades of adaptive automation literature suggest that clinical decision support (CDS) systems that can adapt
to in-the-moment variations in clinician’s fatigue, have potential to intercept fatigue-induced human errors and
preclude potential adverse events.
A criticism of CDS, is that it only provides decontextualized decision support when it has potential to be
adapted to its users (i.e., frontline clinicians). Users with different fatigue level have different needs. When CDS
support is decontextualized, it becomes part of the background that actually contribute to clinician fatigue.
Clinicians not welcoming CDS prompts, develop strategies to avoid interacting with the CDS, which can lead to
negative outcomes. Adaptive CDS would configure itself based on a clinician’s fatigue level to provide the right
level of information, to the right user, at the right time.
The primary objective of this study is to develop the foundation for adaptive CDS in EDs, that is sensitive to a
user’s fatigue and adapts to the user’s fatigue level. A mixed method design will be used to achieve our
objective through two aims: (1) Examine the impact of ED clinician fatigue on (a) clinical decision making and
(b) the use of the CDS for antibiotic prescription; (2) Develop and evaluate CDS design and implementation
guidelines for a CDS that adapts to ED clinician fatigue.
The unique contribution of this study lies in (1) creating a foundation for a novel health information technology
(HIT), adaptable CDS; (2) integrating cognitive decision-making theories into the CDS design; (3) developing a
CDS to accommodate the prevalent negative work condition, fatigue.
Three main deliverables will be disseminated comprehensively. First, we will provide a detailed description of
impact of fatigue on clinical decision making. Second, we will provide a detailed description of impact of fatigue
on the use of clinical decision support systems in EDs. Third, we will report on design guidelines for adaptive
CDS, thereby supporting replicability by other scholars and designers. Eventually, this proposal will improve
clinician’s performance under challenging work conditions, hence patient outcomes.

Public health relevance
Public Health Narrative: Emergency departments provide critical emergency services to every individual who need immediate care and provide SafetyNet to uninsured or underinsured population. Clinician's fatigue which is an important contributor of clinician's burden is a significant obstacle for effective clinical decision making. This innovative study aims to develop clinical decision support systems that adapts clinician's fatigue level in emergency departments.